Balancing Risks and Benefits of Direct Oral Anticoagulants in Older Ischemic Stroke Patients with Atrial Fibrillation

The 2019 U.S. practice guidelines recommend direct oral anticoagulants (DOACs) such as dabigatran, rivarox-
aban, and apixaban over warfarin for stroke prevention in high-risk patients with atrial fibrillation (AF). However,
the selection of a DOAC can be challenging for older ischemic stroke patients. The risk-benefit ratios in second-
ary stroke prevention differ substantially from those in primary prevention. Not only are older stroke survivors at
increased risk for recurrent ischemic events, older age and history of ischemic stroke are also major risk factors
for bleeding complications. While it is known that drug selection should be individualized, it remains unknown
how to tailor anticoagulant therapy according to the effectiveness/safety of the agents and patient unique char-
acteristics. The long-term goal is to use comparative effectiveness research to improve quality of care and out-
comes in patients with cardiovascular disease and stroke. Leveraging the American Heart Association (AHA)
Get With The Guidelines-Stroke Registry (GWTG-Stroke) and Medicare inpatient and Part D database, the over-
all objective of this application is to develop evidence-based strategies to improve appropriate anticoagulant
therapy for secondary prevention in older ischemic stroke patients with AF. The central hypothesis is that differ-
ences exist between DOACs in terms of effectiveness and safety, which have direct implications for therapeutic
selection. Once the relative effectiveness/safety is known, the selection of an anticoagulant can be made based
on patient risk profiles, making treatment safer and more effective. Guided by strong preliminary data, this hy-
pothesis will be tested by pursuing two specific aims: 1) Determine the long-term clinical effectiveness and safety
of different DOACs for secondary prevention in older ischemic stroke patients with AF; 2) Investigate DOACs
dosing patterns and evaluate the potential impact of underdosing or overdosing on long-term outcomes. The
proposed research is innovative in four key ways: 1) A patient-centered approach is used to address a real-life
decisional dilemma facing stroke survivors and clinicians; 2) It shifts focus from selected samples in clinical trials
to a nationwide representative stroke population, including traditionally underrepresented subgroups in commu-
nity practice; 3) A novel propensity score inverse probability weighting method using generalized boosted models
(a machine learning technique) will be employed to mimic a trial-type multi-treatment design, uncover treatment
heterogeneity, and minimize selection bias in observational data; 4) Beyond traditional mechanisms of scientific
publications, the evidence generated from this study will be disseminated to stroke survivors, clinicians, and
relevant stakeholders through the AHA GWTG-led national quality initiatives and patient-led efforts to ensure a
rapid translation of seminal findings into clinical practice. The proposed research is significant because it is
expected to help guide personalized anticoagulant therapy in older ischemic stroke survivors that could best
meet their needs and lead to better outcomes most meaningful to patients. Ultimately, such knowledge has the
potential to inform evidence-based treatment decisions in stroke that now afflicts more than 7.2 million Americans.

Public health relevance
The proposed research will develop patient-centered evidence-based anticoagulant therapy for secondary pre- vention in older ischemic stroke patients with atrial fibrillation. It is relevant to public health because the devel- opment and adoption of personalized evidence-based anticoagulant therapy are expected to reduce recurrent ischemic events, minimize treatment complications, and improve outcomes most meaningful to patients. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will help to enhance health and reduce the burdens of illness and disability.